HPV16 E6 Antibody Detection as an Early Marker for Oropharyngeal Cancer Among Men Living with HIV

People living with HIV (PLWH) have an increased life expectancy due to effective therapies. This has resulted in an
increased incidence of non-AIDS defining cancers (NADCs), in particular, cancers caused by human papillomavirus (HPV).
The most rapidly increasing HPV-related malignancy in the general US population is HPV-driven oropharyngeal cancer
(HPV-OPC), a type of head and neck that has increased in incidence by more than 200% over the past few decades.1, 2
PLWH are 1.5 to 4 times more likely to develop HPV-OPC than the general population.3 They are also more likely to
develop HPV-OPC at younger ages (51 versus 60)4 and have a less favorable cancer prognoses.5 Unlike cervical cancer,
where the introduction of highly effective screening has significantly reduced the incidence and mortality of cervical
cancer, there are no methods for early detection of HPV-OPC. A major barrier for early detection has been the inability
to identify PLWH at highest risk for HPV-OPC given that a precancerous precursor lesion for OPC has yet to be identified.
Recently, HPV16 E6 antibody positivity has been identified as a promising early biomarker. Previous work from our
group showed that HPV16 E6 antibodies are present in up to 90% of HPV-OPC patients6 and appear more than 10 years
prior to diagnosis.7-9 Additionally, we have shown that HPV16 E6 antibodies are highly specific for HPV-OPC10 and are not
strongly associated with the 5 other cancers caused by HPV.11 The objective of this study is to evaluate the ability of the
HPV16 E6 marker to identify a sub-population of PLWH at highest risk for developing HPV-OPC and for which head and
neck cancer screening would be most effective. To accomplish this, we will conduct a natural history study of the HPV16
E6 antibody marker. This study will focus on men aged 40+ living with HIV given that ~85% of HPV-OPC cases occur in
middle aged men and HIV infection additionally elevates risk by up to 4-fold. Using the Tennessee Center for AIDS
Research (TN-CFAR) Biorepository, banked blood samples from men aged 40+ living with HIV (N=3,261) will be tested for
HPV16 E6 antibodies. All HPV16 E6 seropositives and a subset of HPV16 E6 seronegatives (1:2 ratio) will be invited to
participate in yearly (4 total) comprehensive head and neck cancer screening exams performed by a Vanderbilt Ingram
Cancer Center (VICC) head and neck surgeon. Cancer screening visits will include: visual inspection of the mouth and
palpation of tonsils, ultrasound imaging, laryngoscope exam, a detailed questionnaire and biospecimen collection. E6
seropositive men will be compared to E6 seronegative men in terms of: a) markers of elevated HPV-OPC risk and b)
development of HPV-OPC. The specific aims are: (1) Estimate the prevalence of HPV16 E6 antibodies among men aged
40+ living with HIV; (2) Determine the association between HPV16 E6 seropositivity and markers of HPV-OPC risk; (3)
Estimate the risk of developing: a) precancerous markers of HPV-OPC and/or; b) HPV-OPC by HPV16 E6 serostatus. We
hypothesize that men with HPV16 E6 antibodies will be more likely to have known risk factors associated with HPV-OPC
development [sexual behavior, persistent oral HPV infection] and will be more likely to develop HPV-OPC than men
without HPV16 E6 antibodies. These efforts could help to generate evidence for oral health screening guidelines tailored
to PLWH. This work is particularly impactful given that HPV-OPC disproportionately affects PLWH.

Public health relevance
NARRATIVE Cases of human papillomavirus‐driven oropharyngeal cancer (HPV‐OPC) now outnumber cervical cancer cases in the US ‐ men and people living with HIV (PLWH) are at highest risk. Unlike cervical cancer, where the introduction of highly effective screening protocols significantly reduced the incidence and mortality due to cervical cancer, there are no methods for early detection of HPV‐OPC. We are proposing to use HPV16 E6 seropositivity, an early biomarker of HPV‐ OPC, to develop a cohort of men living with HIV who are at highest risk for OPC to better understand HPV16 E6 antibodies as an early marker of HPV‐OPC and b) to develop new methods of early detection for this rapidly increasing cancer.